Biological Imaging Core

Biological Imaging - Summary The Biological Imaging (BI) Module provides state-of-the-art equipment and resources for histological analysis and analytical imaging of biological tissues, for training vision research investigators in the use of these technologies, and to promote new collaborative studies among established and emerging investigators. Specific Aims are: 1) To provide state-of-the-art technology and services for Analytical Imaging and Histology which are beyond reach of individual laboratories, and high-throughput conventional tissue processing 2) To provide training for new investigators and staff on advanced techniques in microscopy, imaging software and other module equipment including preparation of histological tissue and digital graphics production, 3) To promote research of early stage investigators and foster interaction and collaboration among a university-wide, diverse vision research community. The BI module was extensively used in the last grant cycle and was essential for promoting innovative vision research, including testing efficacy of novel therapies, developing and validating viral expression vectors for gene therapy projects, investigating receptor-ligand interactions during disease, identifying biomarkers, and validating proteomics/metabolomics data, as described below. The BI module was used to generate data that was reported in numerous publications and included in new grant awards. This module will continue to provide an essential resource for translational and basic science research for investigators of the McKnight Vision Research center (MVRC).